Discovering catalytic strategies for transition metal-catalyzed reactions to construct topologically complex organic scaffolds

PROJECT SUMMARY
The development of general methods for the construction of sp3-rich (i.e. highly three-dimensional) organic
scaffolds is a longstanding challenge in organic synthesis. High sp3 character imparts beneficial biological
activities and pharmacokinetic properties into organic molecules, but because of their complexity, such
compounds are underrepresented in libraries for drug discovery relative to sp2-rich compounds. Transition metal
catalysis has revolutionized the construction of sp2-rich organic scaffolds, producing an array of general
transformations that allow for the facile synthesis of diverse libraries of compound analogues for developing
novel small molecule therapeutics. To establish similarly versatile methods for synthesizing sp3-rich organic
scaffolds from simple starting materials, innovations in catalysis are needed. The research proposed herein
employs innovative ligand and catalyst design as a means to discover novel and general scaffold-building
methodologies that can transform simple starting materials (i.e. alkenes, dienes, arenes) into functionally and
structurally complex products. In one area, we are developing unconventional ligand platforms that occupy
underpopulated regions of ligand space for Pd catalysis for the development of olefin carbofunctionalization
reactions. We have found that ligands derived from urea, which occupy a region of small organic ligands that is
inaccessible to phosphines and N-heterocyclic carbenes, effectively promote heteroannulation reactions of
ambiphiles and dienes. In addition, phosphine ligands with unconventional steric profiles can exert ligand control
over site-selectivity for heteroannulations with dienes. Future work in this area will focus on expanding on these
findings to develop a unified synthetic approach to preparing diverse aliphatic heterocycles, as well as selective,
multicomponent carbofunctionalization reactions of olefins. These methodological developments will be enabled
by both rational ligand design and computationally-aided ligand discovery. In another area, we are establishing
Cu-diamine complexes as general catalysts for oxidative, radical addition reactions. Central to our reaction
design is coordinating Cu catalysts to the substrate, which promotes selective generation of reactive radical
intermediates that can add to olefins and arenes. Using this approach, we have discovered an aerobic amino-
oxygenation of internal alkenes that engages diverse aryl-substituted alkenes and operates under mild
conditions. Designing ligands that enhance the oxidative potential of Cu and facilitate coordination to substrates
will enable the discovery of new catalytic reactivity in oxidative, radical olefin addition reactions, and provides a
framework for the development of highly enantioselective transformations. These reactions will enable the rapid
construction of diverse functional motifs and cyclic scaffolds with excellent catalyst control over chemoselectivity
and stereoselectivity. In total, the proposed research program will result in the development of versatile catalytic
methods for the efficient preparation of functional molecules that are relevant for discovering compounds with
therapeutic potential, and thus will have a significant impact on biomedical sciences and human health.

Public health relevance
PROJECT NARRATIVE The availability of general synthetic methods that build the carbon framework of organic molecules determines the types of compounds that are available for biological studies and therapeutics for the treatment of human diseases. My research program invents new chemical methods that allow for rapid access to novel small molecules with direct relevance to human health. To accomplish this, we develop new technologies in transition metal catalysis that enable new reactivity and selectivity for C–C and C–X bond forming transformations that prepare functional, highly three-dimensional small molecules.